Data and Research Support Center

PLEDGE Abstract
The Precision Medicine Initiative’s (PMI’s) overarching goal is to transform our understanding of the factors that
contribute to health and disease, and ultimately, to leverage this understanding to information how we prevent
and treat disease. This bold objective will be operationalized in the creation of a longitudinal cohort of 1 million
individuals. The PMI’s coordinating center (CC) (called Partnership in Learning around Engagement, Data,
Genomics, and Environment, or “PLEDGE”) operationalizes this vision, serving as a hub for the PMI Network
leading the optimization of participant engagement strategies, robust data infrastructure, facilitative support of
researchers, coordination and communication between the diverse stakeholders of the Network, and
responsibility for enrollment of the Cohort’s direct volunteers. PLEDGE’s goals are illustrated by four proposed
specific aims: 1) Support the network and its Steering Committee to establish, implement, monitor and reach its
programmatic goals. Serve as a visible national home for the PMI, representing its mission and value to
participants and to health; provide a ‘one stop shop’ storefront for all needs, inquiries, and provision of data
access for high caliber research; 2) Enroll a diverse group of highly engaged direct volunteers without sacrificing
inclusiveness for quantity; 3) Harmonize technical practices among Healthcare Provider Organizations including
data standards, elements, and models, while nurturing innovation from network sites when conformity is not
beneficial. Apply stringent privacy and security safeguards; and finally, 4) Generate support for PMI beyond the
network’s personnel to continuously incorporate new knowledge and tools, by deploying innovative contests,
crowd sourcing, and matchmaking services.

Public health relevance
PLEDGE Narrative The Precision Medicine Initiative will collect comprehensive data from a diverse cohort of 1 million individuals. We will establish the PMI Coordinating Center to enable PMI’s mission: to sustainably improve the health of individuals and populations through the application of new knowledge resulting from rigorous research studies.